Translational Research Activities in Neuropsychiatry (TRAIN) - Renewal - 1

PROJECT SUMMARY
Rapid developments in neuroscientific approaches, technologies, and analytics to understand the
pathophysiology and treatment of mental illnesses have resulted in major advances that serve as a strong
base toward the translation of cutting-edge research into personalized treatments for psychiatric conditions. In
order to best leverage these advances, it is imperative that the next generation of researchers in psychiatry
receive focused training that integrates translational research with clinical training. Psychiatric training
programs that provide this focus, in conjunction with dedicated research time, and leadership and related skill
development, are greatly needed. While there is concern in the field of a profound shortage of physician-
scientists being trained, there is also reason for optimism, in that the number of MD/PhD medical school
graduates applying for psychiatric residencies has increased. Our clinical and translational research training
program, Translational Research Activities In Neuropsychiatry (TRAIN) is designed to provide exceptional
training and mentoring to psychiatry residents with the express goal of generating clinical and translational
researchers in psychiatry who will go on to become independent physician-scientists. This program focuses on
the relationship between disruptions in underlying genetics and neurobiology and how they relate to adaptive
behavior, as in the NIMH Research Domain Criteria (RDoC) framework, as well as the emergence of
biomarkers that can inform clinical care. The TRAIN program harnesses the expertise and processes our
faculty employ to bridge existing gaps in the field. This includes focused work and expertise in critical content
areas, populations, and settings, as well as the use of approaches that span all ranges of translational science
from the bench to the community. Our structured program provides an exceptional mentoring plan with
experiential opportunities to participating residents coupled with timely didactics. The TRAIN program is
specifically designed to train the next generation of researchers so that they can translate neuroscience and
genetics research into advancements of our understanding of a wide range of mental health problems and
treatments. TRAIN facilitates team science mentoring and training that is needed for translational research,
with an emphasis on productivity through the conduct of a mentored research project, as well as deliverables
such as networking and development of funding proposals to equip trainees for their next steps in training and
academic research. TRAIN also focuses on wellness and guarding against burnout to encourage early
adoption of self-care and enhance resilience.

Public health relevance
PROJECT NARRATIVE Advances in the fields of neuroscience, genetics, and other biological fields are leading to profound transformations in our understanding of mental health. In order to translate this understanding into new and optimized treatment approaches, research training should encompass a solid foundation in translational science. Consistent with the Research Domain Criteria (RDoC) initiative and emerging work on the use of biomarkers to guide prediction of disease development and treatment response, our Translational Research Activities In Neuropsychiatry (TRAIN) program is designed to train the next generation of physician-scientists in psychiatry so that they can translate neuroscience and genetics research into better outcomes for individuals with mental illness.